Mitochondrial function regulates ROS-mediated patterning following injury

Abstract
Mitochondria are critical for generating energy. Recently a new role for mitochondria in controlling metabolic
signaling through generation of reactive oxygen species (ROS) has come to light. ROS has also recently come
into the spotlight as being a critical signaling axis for limb regeneration, and while mitochondrial signaling has
been well-established in cell homeostasis, the role of mitochondrial generated ROS and its downstream
mechanisms in controlling regeneration is not clear. Using the established mouse digit tip amputation
regeneration model, spatial transcriptomics, and unique transgenic mice, we uncovered a unique role for two
mitochondrial regulatory proteins, BNIP3 and NIX, in regeneration. Our preliminary findings support that
regeneration is dependent on the mitochondrial regulation protein BNIP3, and that this protein supports ROS-
generated, directional morphogenetic signaling gradients from the wound epithelium. Further, our preliminary
data support that a second mitochondrial regulatory protein, NIX, serves to support blastema maturation and
differentiation, a structure critical to regenerating the bone and soft tissue. We hypothesize that BNIP3 and NIX
function in a spatially distinct relationship where NIX supports differentiation in the blastema in response to
adjacent signaling gradients generated by BNIP3 in the wound epithelium. This project would provide the first
evidence of a BNIP3/NIX signaling access in injury, implicating mitochondrial function and mitophagy as spatial
regulators of the regeneration process, and giving a broader context to a mitochondrial homeostasis mechanism
that is salient to many fields.

Public health relevance
Narrative Mitochondria are essential for cell survival not only as sources of ATP but also as factors that control intracellular signaling. The role of mitochondrial generated ROS and signaling in regulating bone regeneration is currently unknown. This proposal seeks to identify the role of two novel mitochondrial related factors BNIP3 and NIX in regulating digit regeneration to elucidate mechanisms that can be targeted to enhance bone regeneration.